Defining native glutamate receptor diversity

SUMMARY
Glutamatergic synapses have an exceptionally diverse proteome consisting of more than 1000 highly conserved
proteins, and mutations in synaptic proteins cause varied behavioral consequences. Limited knowledge of
molecular organization among glutamatergic synapses hinders our understanding of how synapse diversity
contributes to brain function and results in generic, often ineffective, therapies. Our goal is to advance rational
therapy design that selectively targets disrupted brain circuits by defining the organization, function, and
therapeutic potential of precise synaptic glutamate receptor populations. This project seeks to define the
composition and organization of native glutamate receptor complexes by overcoming long-standing technical
challenges in receptor biology. We study molecular organization at glutamatergic synapses in the thalamus due
to its exceptionally diverse glutamatergic input and gene expression as well as its involvement in varied diseases.
Our recent work suggests key roles for the N-methyl-D-aspartate receptor (NMDAR) family of glutamate
receptors in the specialized signal processing duties of the thalamus. NMDARs are tetramers that can assemble
in various subunit combinations with distinct functional properties, and thus distinct therapeutic potential.
Remarkably, we still do not know which subunit combinations exist in native brain tissue. We hypothesize that
NMDAR subunits preferentially assemble in particular combinations with specific associated macromolecular
complexes that lead to distinct subcellular organization in the brain. The proposed work utilizes innovative
approaches including novel biochemical strategies, super-resolution imaging, and genome editing techniques to
determine: 1) the diverse composition of native NMDAR macromolecular complexes, and 2) how NMDAR
localization generates molecular diversity at synapses. Outcomes of this project will guide treatment strategies
in ongoing studies with mouse disease models as well as sustained efforts in developing subtype-selective
NMDAR modulators. Moreover, this approach could be applied to a number of neurotransmitter receptor
families, and thus has the potential to advance therapy design for many neurological diseases.
1

Public health relevance
NARRATIVE Defining the mechanisms that generate molecular and functional diversity at native synapses is central to understanding complex behavior and treating human disease. The lack of knowledge regarding synapse diversity forces clinicians to use broad disease therapies. This project will define native glutamate receptor diversity, and thus identify novel targets for modulating select brain circuits that limit adverse effects of needless brain-wide modulation caused by broad treatments.